Inflammatory Nicotinic Acetylcholine Receptors in a Genetic Model of Essential Hypertension

Nearly half of US adults have hypertension. Hypertension is also highly prevalent in the VA Health
System. Traditionally, hypertension has been thought to be a function of abnormalities in the renal,
vascular, and nervous systems. In recent years, clinical and basic science data clearly demonstrate that
there is crosstalk between the nervous and immune systems, and the neuro-immune axis plays an integral
part in development of hypertension.
The neuro-immune axis describes a regulatory, bidirectional interaction between the autonomic
nervous and immune systems. Activation of the nicotinic arm of this axis leads to both anti- and pro-
inflammatory immune responses. We discovered that activation of the nicotinic acetylcholine receptor with
nicotine (a non-selective agonist), both in vitro and in vivo, induces an inflammatory M1 macrophage
population that infiltrates the renal medulla and leads to the development of hypertension in the genetic
Spontaneously Hypertensive Rat (SHR) model of essential hypertension. Our long-term goal is to develop
novel therapeutic agents to target this cholinergic arm of the neuro-immune axis in human essential
hypertension. The short-term goal of this proposal is to identify the nicotinic acetylcholine receptors
involved in this cholinergic arm, and to explore their role in the development of essential
hypertension.
The central hypothesis of this proposal is that a specific arm of the nicotinic acetylcholine receptor-mediated
immune response favors inflammatory mechanisms to promote the development of hypertension. This
hypothesis is grounded in novel and exciting preliminary data showing that the alpha4beta2 subtype
of the nicotinic acetylcholine receptor is upregulated in immune cells in the SHR model of essential
hypertension, and that selective activation of the alpha4beta2nicotinic acetylcholine receptor leads
to the development of hypertension. Using state-of-the-art in vivo and in vitro molecular and cellular
approaches, as well as in vivo hemodynamics, this proposal will 1) determine the role of the
alpha4beta2 subtype of the nicotinic acetylcholine receptor in pro-inflammatory immune cells
responses; 2) explore whether the alpha4beta2 nicotinic acetylcholine receptor plays a causal role
in the development and maintenance of essential hypertension; and 3) examine whether splenic
innervation promotes expansion of immune cells endowed with the alpha4beta2 nicotinic
acetylcholine receptor, and thus an inflammatory phenotype, in essential hypertension.
Essential hypertension is the most prevalent cardiovascular condition in the VA Health System and
remains undertreated. Major gaps in our understanding of the neuro-immune axis limit our ability
to treat hypertension. This application provides a unique opportunity to better understand this axis
and may therefore open the door for new anti-hypertensive therapeutics.

Public health relevance
The current proposal is directly relevant to the health of U.S. military veterans because it will investigate mechanisms involved in the detrimental actions of activating nicotinic receptors, leading to the development of hypertension. Hypertension is a significant risk factor for cardiovascular disease. Nicotine use, hypertension, and cardiovascular disease are highly prevalent among veterans. Nicotine selectively leads to the development of hypertension in a subset of patients. The receptors that bind nicotine, can also be activated by endogenous molecules such as acetylcholine, a neurohormonal molecule present in the body. Results from this study will identify the receptor involved in nicotine-mediated hypertension, inflammation, and determine whether endogenous acetylcholine activates nicotinic receptors, leading to the development of hypertension. Determining the ability of acetylcholine to trigger the development of hypertension through a particular nicotinic receptor will lead to new therapies that will directly benefit the veteran population.